Developmental Origins of the Sturge Weber Syndrome Somatic Mutation

Abstract: Sturge Weber Syndrome (SWS) is a sporadic (non-inherited), developmental, neuro-cutaneous
syndrome characterized by a capillary vascular malformation affecting the skin of the face, and abnormal
capillary venous vessels in the leptomeninges of the brain and choroid. The choroidal vascular malformations
lead to glaucoma, and the leptomeningeal vascular malformations lead to epilepsy, stroke-like episodes, and
cognitive impairment. In 2013 we (a multi-institutional team) identified the cause of SWS by whole genome
sequence analysis. The identical somatic mutation (c.548G→A, p.R183Q) in GNAQ (encoding Gαq) was
identified in affected tissue that was absent in unaffected tissue from the same patients. Despite this discovery
over a decade ago, to date, no fully faithful animal model of the disease has been developed. We hypothesize
that the lack of a robust mouse model is due to two significant gaps in knowledge that need to be answered
before any truly faithful animal model can be generated. Our central hypothesis is that SWS occurs 1) only if
the causative somatic mutation occurs in a particular fetal cell type during development and 2) only when it
occurs within a specific developmental time window. We recently published a mouse model of SWS, using
conditional allele integrated into the endogenous locus that expresses the mutant version of GNAQ only upon
Cre recombination. These mice develop vascular malformations in the embryo but are embryonic lethal. We
propose to address the two gaps in knowledge listed above using our novel transgenic model to identify the
developmental time window when the embryonic vascular malformations form, and then using
transcriptomics, to identify the cell type in the earliest developing lesions that expresses mutation. These
experiments will provide critical information about SWS pathogenesis, that will in future studies, us to then
integrate this knowledge to generate a faithful mouse model - or different, organ-specific models - of the
disease. In future work beyond the scope of this study, our mouse models will enable mechanistic studies on
SWS pathology in the various organs affected.

Public health relevance
Project Narrative: Sturge Weber Syndrome (SWS) is a developmental disorder affecting newborns and persisting throughout life, leading to glaucoma, epilepsy, stroke-like episodes and other disabilities. SWS is caused by a genetic mutation that occurs while the fetus is growing in the womb. The goal of this project is to determine the origins of this mutation during fetal growth, and to use this information in the future to create a mouse model of SWS to test new treatments.